IGF::CL::IGF: This service is for events planning and travel portion of the Annual Pain Consortium meeting.

This service is for events planning and travel portion of the Annual Pain Consortium meeting.